Studying EGFR where it lives: How membrane lipids define receptor properties

PROJECT ABSTRACT
There is no doubt that the complex lipid makeup of the membrane bilayer and the associated peripheral
membrane proteins dictate integral membrane protein (IMP) structure, function, localization, and dynamics in
vivo. Yet, all this is replaced with detergents in traditional in vitro studies of IMPs due to technological limits.
Indeed, the rapidly advancing G protein-coupled receptor and ion channel fields are showing us that both
tightly bound and loosely-associated membrane lipids play crucial roles in defining receptor behavior. Current
structural understanding of receptor tyrosine kinases (RTKs) seems extensive; however, we lack the
fundamental knowledge of how RTKs are regulated by and transmit signals though the plasma membrane.
Recent data have revealed this as a major shortcoming, as lipid-like antidepressants are thought to bind and
modulate tropomyosin receptor kinase B and to quell aberrant epidermal growth factor receptor (EGFR)
signaling in glioblastoma (by altering sphingolipid metabolism). EGFR, is an RTK that plays crucial roles in
cellular and lipid metabolism, differentiation, motility, and proliferation in cancer. EGFR is a member of the
ErbB family which has an extracellular-ligand binding domain linked to its intracellular kinase signaling domain.
Monomeric EGFR is canonically regarded as inactive and ligand binding activates the receptor by driving
formation of an asymmetric kinase dimer; both the active and inactive states are associated with different lipid
microenvironments. Numerous structures have shown how individual RTK domains function in isolation and
full-length EGFR (FL-EGFR) studies have revealed only another ectodomain structure due to being performed
in a non-native membrane environment, omitting crucial lipid-cofactors. Ideally, one would study (FL-EGFR) in
the context of the appropriate endogenous plasma membrane environment. However, the necessity to replace
the bilayer with detergent during membrane protein isolation has made this historically impossible. To address
this, I will combine newly available key technologies to define in vivo membrane protein environments and
investigate lipid co-factor impacts on FL-EGFR structure and function. Aim 1 seeks to understand how the
bilayer environment controls EGFR function with kinetic assays of FL-EGFR in defined lipid compositions
will be used to understand the enzymatic influence of literature-identified lipid co-factors. Lipid compositions
that significantly alter EGFR’s enzymatic properties will then be used to develop a comprehensive “real”
structural study. The results in artificial bilayer systems will be validated with FL-EGFR in native nanodiscs
which allow for study of membrane proteins along with their native lipid environment. Aim 2 asks what are the
bilayer environments of EGFR? Numerous studies propose EGFR to reside in multiple poorly-defined bilayer
environments: one in the ligand-bound active dimer state, and another in the inactive monomer state. Native
nanodiscs and mass spectrometry-based lipidomics will characterize and compare the membrane and protein
compositions in these two distinct environments.

Public health relevance
PROJECT NARRATIVE Membrane proteins represent ~30% of the mammalian proteome and over half of all drug targets, but are nearly always studied in physical contexts that do not model their relevant membrane environments – and this is limiting understanding. We seek to understand the role of the native membrane environment on epidermal growth factor receptor, a membrane protein that plays crucial roles in cellular and lipid metabolism, differentiation, motility, and proliferation in cancer.